SWG 11: Substance Use

Project Summary/Abstract
The Substance Use Scientific Working Group (SU SWG) is proposed to stimulate interdisciplinary scientific
collaboration to investigate the intersection of substance use and HIV, an area that is critical to address to end
the national and global HIV epidemics. There is renewed interest and urgency to enhance research on substance
use and HIV, in part due to the opioid crisis being associated with HIV outbreaks in parts of the US, including
Seattle, and increasing rates of methamphetamine use, being associated with high-risk sex. Furthermore,
substance use still strongly drives disruptions and disparities in the HIV care continuum, including continuation
in HIV care and adherence to ART which are needed for “treatment as prevention”. The SU SWG will bring
together CFAR investigators from varied backgrounds with a shared interest in tackling the unique issues facing
persons with substance use disorders living with, or at risk for, HIV, particularly people who inject drugs (PWID)
who are a key vulnerable population. The SU SWG addresses a key NIH HIV priority area furthering “research
that examines health and social issues, such as other infectious or non-infectious conditions and substance use
or mental health disorders”. We will support research to understand current patterns of substance and
polysubstance use, including opioids, stimulants, sedatives, cannabis, alcohol, and nicotine, among persons
living with HIV and those at risk of acquiring HIV, and to elucidate how they impact HIV disease transmission
and outbreaks. We will also foster research to develop and test patient-centered interventions, both biomedical
and behavioral, that will prevent and/or treat HIV among persons with substance use disorders and research
that will integrate care for addictions and HIV. Our overarching goal is to bring together a multi-disciplinary
community of researchers dedicated to advancing the research agenda for substance use and HIV prevention,
treatment, and cure. Our Specific Aims are to: 1) create and support a multi-disciplinary network of UW
researchers with diverse backgrounds and expertise to develop substance use research and receive
critical feedback on projects and grants. 2) cultivate new skills and knowledge related to substance use
and HIV research among early stage investigators and those new to HIV or substance use research,
particularly those from diverse and underrepresented backgrounds. We will leverage and create
multidisciplinary collaborations between diverse researchers on substance use at our CFAR, support monthly
work-in-progress meetings, and host an annual workshop for skills development specific to the intersection
between substance use and HIV. Our efforts will include a focused effort to support early stage investigators.
This work will be done in collaboration with the CFAR Office of Community Engagement to ensure that
community priorities are addressed. With this new SWG, we will leverage the substantial momentum building
around research on HIV prevention and improved HIV care for persons with substance use and use disorders to
position our CFAR to be a leader in the field of substance use and HIV.